Targeting natural killer cells to enhance HIV vaccine responses

PI: Waggoner, Stephen Noel, “Targeting natural killer cells to enhance HIV vaccine responses”
ABSTRACT
Immunization represents one of the most successful public health interventions in human history, preventing
more than 2 million deaths each year. Most licensed vaccines work by eliciting antibodies that can prevent
infection by neutralizing the invading pathogen. However, vaccine-mediated induction of broadly neutralizing
antibodies capable of thwarting infection with a highly mutable pathogen like HIV has proven exceptionally
difficult in both humans and animal models. This shortcoming in vaccine success is likely due to intrinsic immune
regulatory mechanisms that limit the quantity and quality of immune responses. Development of translational
means to overcome these immunological roadblocks holds great promise for advancement of next-generation
vaccines to prevent infection and improve global health.
Our research focuses on the remarkable capacity of natural killer (NK) cells to suppress T and B cell responses.
NK cells limit the magnitude and quality of adaptive immune memory triggered after immunization. This activity
of NK cells impairs the generation of protective neutralizing antibody responses by restricting somatic mutation
and affinity maturation of these antibodies within germinal centers. We find that a subset of transcriptionally
unique NK cells migrates to sites of germinal center formation following immunization and contributes to
suppression of follicular helper T cells (Tfh) differentiation via perforin-mediated elimination of activated CD4 T
cells. We identify key effector molecules, receptors, and transcription factors that are putatively vital for this
immunosuppressive activity of NK cells, and therefore represent innovative targets to enhance vaccine efficacy.
The overall objective of this proposal is to test the scientific premise that cytotoxic functions of NK cells limit
vaccine-mediated generation of HIV-specific broadly neutralizing antibodies. We propose three thematically
connected aims that explore the contributions of various mediators that determine the cytotoxic
immunoregulatory capacity of NK cells during immunization. In Aim 1, we will use cutting-edge knock-in mice to
test the hypothesis that transient small molecule inhibition of NK-cell cytolytic function during immunization can
safely and effective augment germinal center-mediated maturation of HIV-specific antibody responses. In Aim
2, we will use innovative bone marrow chimera and conditional knock-out mice to define the role of a network of
transcription factors, chemokine receptors, and integrins in localization of NK cells near developing Tfh to
facilitate cytolysis of these target cells. In Aim 3, we will use a new strain of mice and pioneering CRISPR-based
screens to discover receptors involved in promotion or restraint of NK-cell killing of CD4 T cells. These
experiments will define factors that enable and calibrate NK-cell suppression of adaptive immune responses
during infection. Thus, the proposed work will facilitate subsequent development and deployment of innovative
strategies to enhance HIV vaccine efficacy.

Public health relevance
NARRATIVE (Public Health Relevance) HIV remains a global pandemic with no efficacious vaccine to prevent the millions of new infections that occur each year. This proposal explores mechanisms of natural killer cell suppression of vaccine responses that represent immunoregulatory roadblocks preventing vaccine elicitation of protective, broadly functional HIV- specific neutralizing antibodies. The outcomes of this study will include advancement of translational targets for enhancing the capacity of next-generation HIV vaccines to engender immune responses that prevent HIV infection.